DEIA Mentorship Supplement

Project abstract
The research proposed in this supplement study expands on the parent study, which aims to determine
interrelationships among abdominal fat accretion, sedentary behavior during pregnancy, and maternal
cardiorespiratory fitness (CRF), and the independent and interactive effects on GDM risk, defined as insulin
sensitivity and β-cell function. Our proposed study will characterize current physical activity patterns using
accelerometer data collected in a racially-diverse group of 115 pregnant women from the parent study at each
trimester (Aim 1), and will further determine associations between free-living moderate and vigorous activity
levels and our two primary metabolic outcomes, insulin sensitivity (Aim 2A) and β-cell function (Aim 2B) at 26-
28 weeks gestation. If funded, this supplement award will also provide support for five student trainees to help
conduct this research and participate on our supportive and engaging team environment at Kennesaw State
University, a large, undergraduate-focused R2 university.

Public health relevance
Project narrative Gestational diabetes is a dangerous condition affecting nearly 1 in 10 pregnancies and is associated with risk of future obesity and diabetes in the child. Physical activity in pregnancy has been found to be protective, but researchers do not know exactly how much and what type is needed. Our research team will measure physical activity in a racially-diverse group of 115 pregnant women to determine the current activity patterns and also how much moderate and vigorous activity is needed to help protect against gestational diabetes.